Defining the molecular landscape of hyperfiltration-mediated glomerular injury using kidney allografts as a model system

ABSTRACT:
Long-term kidney allograft survival has not improved significantly over the last two decades. Accumulating
data supports the hypothesis that progressive glomerular disease drives late kidney allograft failure, with hyper-
filtration mediated glomerular injury being a putative driver. In addition, hyperfiltration is implicated in the progres-
sion of kidney diseases such as in diabetes and obesity, both of which have reached epidemic proportions. How-
ever, the molecular underpinnings of this shared mechanism of kidney disease progression remain unclear and
forms the scientific basis of this proposal.
My long-term goal is to understand disease mechanisms driving late allograft loss, with a focus on prolonging
allograft lifespan. The overall objective of this application is to elucidate the molecular mechanisms by which
hyperfiltration initiates and drives the podocyte detachment process in kidney allografts. We will also test whether
parallel mechanisms are operating in an independent cohort of hyperfiltering diabetic patients.
Towards achieving this objective my central hypothesis is that hyperfiltration leads to a characteristic molec-
ular footprint in the glomerulus that drives podocyte stress and accelerated detachment. To identify the underlying
molecular mechanism of hyperfiltration, a combination of bulk- and single cell RNA-sequencing technology will
be used to identify glomerular cell-specific gene signatures as well as interactions between cells associated with
the glomerular basement membrane that are known to drive podocyte detachment. To enable non-invasive mon-
itoring of podocyte loss, we will use urine pellet podocyte detachment assays and measure hyperfiltration using
filtration fraction studies. We will test the central hypothesis using three specific aims:
Aim 1. Define the glomerular transcriptional response to hyperfiltration.
Aim 2. Define the glomerular transcriptional profile that drives accelerated podocyte detachment and identify
the effect of hyperfiltration on this relationship.
Aim 3: Define the relationship of allograft hyperfiltration with podocyte stress and detachment.
The research is innovative as it uses human kidney allografts as a model system to focus on hyperfiltration
as a common mechanism of kidney disease progression analyzed by state-of-the-art technologies. The proposed
research is significant as the identification of shared pathways of disease progression between kidney diseases
could lead to the development of novel targeted therapeutic agents and non-invasive monitoring strategies. Ulti-
mately, such knowledge will be crucial to slow down kidney disease progression regardless of its etiology.

Public health relevance
LAY SUMMARY: The proposed research has broad relevance to public health as it focuses on improving our understanding of the molecular basis of a shared mechanism of kidney disease progression, i.e., renal hyperfiltration injury. Kidney transplants will be used as a model system to test how hyperfiltration causes kidney damage in humans. We expect the findings to be broadly applicable to common kidney disease states such as diabetes and obesity that are also accompanied by hyperfiltration. Insights from this analysis we be applied to prolong the lifespan of kidney transplants and reduce morbidity and mortality associated with chronic kidney disease.